Human-Centered Development of Guide-dog Robots

Project Summary
In the U.S., over one million individuals live with severe visual impairments, a ﬁgure projected to double in the next
30 years. Guide dogs offer independent, natural, and safe mobility assistance, allowing handlers to walk at speeds
comparable to sighted peers and navigate dynamic environments safely. However, only 2% of this population has
access to guide dogs, primarily due to the limited supply of these highly trained animals. The signiﬁcant cost and
time required to train and deploy guide dogs (approximately $50,000 USD and 2 years) and their relatively short
working span (less than 10 years) are major barriers. Additionally, guide dog handlers must provide continuous
care, including medical attention, feeding, and daily exercise. Despite their compelling beneﬁts, these challenges
make guide dogs a less scalable and sustainable solution for the wider visually impaired community.
Motivated by recent progress in quadruped robots and their potential for mass production and long-term
sustainability, we are determined to create a practical guide-dog robot as an additional solution for navigation
assistance for blind or low-vision (BLV) people. We are dedicated to aligning our development process with
the authentic needs of end-users, adopting a human-centered design philosophy that involves key stakeholders
throughout every stage of the process, including: 1) deﬁning the robot’s speciﬁcations, 2) developing algorithms
and integrating them into a single robotic system, and 3) conducting evaluations, identifying unforeseen issues,
and iteratively reﬁning the hardware and algorithms. Our proposed research is grounded in our comprehensive
qualitative study, which included semi-structured interviews with 23 guide-dog handlers, ﬁve trainers, seven ob-
servation sessions, and two blindfolded guide-dog walking experiences. Our prior work revealed the limitations
of existing quadruped robots for the BLV population and pinpointed critical areas for development. Rooted in our
extensive understanding of the interaction between guide dogs and their handlers, we offer technological inno-
vations such as: 1) new quadruped robot hardware developed through a human-centered approach, featuring
compactness, portability, extended operation, and multi-modal sensing (e.g., tactile, audio, and vision), 2) a novel
co-optimization framework for robot hardware and controllers to create a robotic navigation assistant optimally
designed for BLV people, and 3) a robust navigation algorithm that adapts to scene variations by creating a novel
self-supervised learning framework.
Our core innovation lies in introducing a human-centered development approach to creating a guide-dog robot,
addressing the signiﬁcant open problem spanning hardware conﬁguration to navigation algorithm development.
The developed technology will be consolidated into a single quadruped robot, which will undergo rigorous evalua-
tions by guide-dog handlers and white cane users. The successful completion of this project will yield an effective
navigation system for BLV individuals and trigger a paradigm shift in the ﬁeld of guide-dog robot research.

Public health relevance
Project Narrative The proposed research aims to create a robotic system for the signiﬁcantly enhanced independence and quality of life of people with blindness or low vision. To address the real-world technical needs of end users, our research will apply a human-centered design philosophy throughout the iterative development process and facilitate deep engagement with crucial stakeholders, such as guide-dog handlers and white cane users.